Function-based exploration of genetic variation at genome-scale

PROJECT SUMMARY
Genome-wide association studies have discovered thousands of genetic variants associated with phenotypic
traits such as disease risk. Most of the associated variation lies within non-coding regions of the genome and
the causative effects of those variants remain largely unknown. The sparsity of knowledge on interactions
between the coding and non-coding regulatory parts of the genome makes the prediction of variant function
solely from genome sequence and location impossible. We propose to experimentally uncover the functional
relevance of genetic variants at a large scale, by perturbing variants and genetic elements containing variants,
and reading out the direct consequences of those perturbations on gene regulation. To this end, we propose to
apply our recently developed CRISPR/Cas9 functional genomics screening technology with targeted single-cell
transcriptomic readouts (targeted Perturb-seq or TAP-Seq in short) to enable systematic interrogation of non-
coding regions and genetic variation therein. First, we will apply our targeted Perturb-seq to decipher the
regulatory circuitry encoded on an entire human chromosome by systematically perturbing all major genetic
elements (enhancers, protein-coding and lncRNA genes). This extensive data set will enable to decipher the
complex regulatory networks controlling gene expression on the selected chromosome. Next, we will uncover
causal regulatory variants in these regions by coupling high-throughput precision genome editing to
simultaneous single-cell genomic and transcriptomic readout. Using this novel approach, we will be able to
decipher the functional impact of genetic variants on gene expression and derive rules by which genetic variation
perturbs gene regulatory processes. We will integrate the generated data with available functional genomics
data, such as transcription factor binding (ChIP-seq), chromatin accessibility (ATAC-seq, DNAse-seq) and
interactions in 3D (Hi-C), in order to train machine learning models to derive rules of the observed regulatory
interactions. These models will be applied to decipher the molecular mechanisms underlying the regulatory logic,
and to predict regulatory interactions and variants throughout the genome and across cell types. Selected
predictions will be experimentally validated using the established perturbation technologies, to verify clinically
relevant predictions and improve the performance of the predictive models. Taken together, this project will
answer fundamental questions in gene regulation, uncover the mechanisms by which genetic variation impacts
gene expression, and create datasets and computational models as valuable tools for interpreting results from
GWAS, eQTL and clinical genomic studies.

Public health relevance
NARRATIVE A promise of precision medicine is that individual genome sequence data will enable the determination of disease risk and effective treatments, however unravelling contributions of genetic variation to disease remains one of the greatest challenges in genomics. By combining DNA editing with single-cell transcriptomics, we will experimentally decipher regulatory networks for a whole human chromosome and engineer hundreds of genetic variants to uncover their gene regulatory effects. This data will be used to train machine learning models to predict regulatory interactions throughout the genome and across cell types.